Developing high-precision epigenetic therapeutics for opioid use disorder

Abstract
Opioid abuse disorder (OUD) is a growing epidemic that disrupts numerous lives and local communities
in the United States. No effective therapeutics exist to counter the addiction; current OUD therapeutics
such as methadone, buprenorphine, and naltrexone are opioid mimetics, either exerting weaker potency or
blocking the opioids from binding with their cognate receptors. Epigenetic modifications on histone
marks play key causative roles in mediating opioid addiction. Such epigenetic modifications generate
“persisting impacts” on the reward circuitry of the brain by altering chromatin structure and synaptic
rewiring. Unfortunately, current epigenetic drugs are not suitable for drug addiction therapeutics. The
fundamental problem is that epigenetic regulators play numerous roles in different tissues and under
diverse cellular contexts; thus, enzyme-inhibitory epigenetic drugs tend to cause very high off-target
toxicities that are unacceptable outside of oncological indications. Recently, we developed a novel
approach that identified high-precision small-molecules by targeting protein-protein interactions (PPI) of
an epigenetic protein complex involving histone deacetylase (HDAC). In particular, we demonstrated a
SIN3-binding molecule that disrupts the HDAC SIN3 complex recruitment to chromosomal loci. This
molecule could block LSD-induced hallucination as effectively as a genetic HDAC2 knockout in the
mouse prefrontal cortex, while only minimally inducing off-target gene expression. By adapting this
approach, we seek to develop high-precision PPI-targeting molecules for OUD. The neuronal G9a
complex is an attractive target regulating ΔFosB expression under chronic opioid exposure. We will apply
a mammalian cell-based compound screening platform to identify functional modulators of the G9a
complex and biophysically characterize their drug-protein interactions. The efficacy and specificity of the
final hits will be tested in OUD animal models where behavioral responses and biomarkers in the brain
will be examined. We aim for our work to result in an effective, epigenetically targeting OUD therapeutic
that helps individuals impacted by this condition to recover safely.

Public health relevance
Project Narrative The growing OUD epidemic derails the lives of numerous productive young Americans, yet effective therapeutics are lacking to reduce the burden of opioid addiction. Developing high-precision PPI therapeutics against the epigenetic G9a complex could yield a safe and effective therapeutic. Our team will develop lead PPI compounds against the G9a complex, epigenetically targeting the main mechanism of opioid addiction in the brain.